Development of a first-in-class nonmuscle myosin II inhibitor to prevent substance use disorder relapse

PROJECT SUMMARY
In 2018, over 1 million people in the U.S. qualified as having a methamphetamine (METH) use disorder and
rates of METH use are surging, largely in response to the opioid epidemic. METH use disorder is a chronic
condition for which there are currently no FDA-approved medications. The only treatment options available are
behavioral modification therapies, which have limited efficacy, as evidenced by the high rate of relapse (60-
90%). This argues for an adjunct pharmacotherapy targeting relapse triggers to support abstinence. Rigorous
prior research from our group and others has established that relapse triggered by reminders of drug use bear
a powerful motivational influence, serving as a lifelong relapse risk factor, regardless of how long an individual
abstains. Myosin Therapeutics is currently developing MT-110 as a non-stimulant, first-in-class drug targeting
the molecular motor nonmuscle myosin II (NMII). Blebbistatin (blebb) was the first NMII allosteric inhibitor to be
discovered and suffers from poor tolerability due to equipotent inhibition of cardiac muscle myosin (CMII). MT-
110 is a blebb analog with improved brain exposure, potency, and selectivity for CMII (>100x) which greatly
improves its therapeutic index. MT-110 is currently in IND-enabling studies with a plan to enter a Phase 1 SAD
towards the end of 2021. It is being developed as a short-term administration medication to support abstinence
through a disruption of the motivation to seek METH. A primary goal of this Fast-Track SBIR application is to
establish MT-110’s safety profile with multiple administrations, as it is expected to benefit subjects refractory to
single administration treatment or those that relapse due to another factor. Establishing MT-110’s efficacy in the
context of polydrug use and other SUDs will also expand its therapeutic value. In Phase I of the grant, a repeat
dose non-GLP dose range finding (DRF) study in rats is planned to determine the tolerability of the test article
(MT-110) and to identify potential dose limiting toxicities, toxicokinetics and target organs. A cardiac safety
assessment with electrocardiography will be run in parallel in rat to ensure no effects on cardiac contractility,
consistent with the dramatic improvement in MT-110’s selectivity profile for NMII over CMII. Milestone driven
transition to Phase II of the grant initiates with an IND-enabling GLP safety pharmacology study in rats to
determine potential toxic effects, identify target organs of toxicity, estimate the MTD and NOAEL, evaluate the
TK, and reversibility of any adverse effects following repeated dose administrations. Assessment of repeat MT-
110 dosing in a non-GLP DRF study in dogs will establish potential dose limiting toxicities, toxicokinetics and
target organs in a second species. While the improved selectivity of MT-110 is expected to reduce the impact
on cardiac output, chronic METH use can lead to cardiomyopathy. Therefore, we will establish the tolerability of
MT-110 in the context of METH-induced cardiomyopathy in rats. Additionally, in this Administrative Supplement
application, we seek funding to perform expanded safety and tolerability studies, as they could not be foreseen
because the application was submitted and funded prior to the pre-IND meeting. To directly address the guidance
Myosin received, we are proposing to perform GLP and non-GLP behavior assays and spine density analysis.
Importantly, these studies will help to ensure a strong IND package and MT-110’s continued momentum to the
clinic. Finally, MT-110’s efficacy will be determined in the context of other substance use disorders. The ability
of MT-110 to disrupt seeking of heroin, cocaine or nicotine in METH users would increase treatment options in
a rapidly escalating polydrug use epidemic.

Public health relevance
PROJECT NARRATIVE Rates of methamphetamine (METH) use and accidental overdose deaths are surging and there are currently no medications for treatment, leaving only abstinence support and various behavioral modification therapy modalities. Myosin Therapeutics is developing a first-in-class nonmuscle myosin II (NMII) small molecule inhibitor, MT-110, where preclinical studies indicate that short-term administration with MT-110 produces a long- lasting, potentially permanent, disruption of the motivation to seek METH. Expanded safety and tolerability studies proposed in this Fast-Track SBIR application will expand the IND opened for MT-110 under our NIH funded Blueprint Neurotherapeutics (BPN) program, ensuring a rapid initiation of a Phase 1 MAD and the greatest flexibility for design of subsequent proof of concept clinical Phase 2 studies.